Regional Biocontainment Laboratory (RBL) Upgrade for Colorado State University (CSU)

Project Summary / Abstract
The funding and implementation of this supplement is essential to maintain uninterrupted research and
scholarly activity in CSU’s Rocky Mountain Regional Biocontainment Laboratory (RMRBL). Research
activities that occur at the RMRBL directly address the RBLs’ missions to respond to and prevent global
infectious disease threats. Our efforts are the evolution of over 4 decades of research conducted at CSU
predominately sponsored by NIAID, and includes interdisciplinary research teams studying Flaviviridae,
Togaviridae, Bunyavirales, Coronaviridae viral pathogens along with robust programs in mycobacteria,
anti microbial resistance, and vector borne bacterial pathogens. The RBL is integral for this infectious
disease research, training and other scholarly activities. The RMRBL recently benefitted from a G20
award specific to much needed modernization and infrastructure upgrades. However, these investments
continue to be needed due to the complexity and high use of this facility. Here, we add to the Specific
Aims of our parent G20 award to continue to make critical investments to improve our biosafety, animal
modeling, and imaging research needs.

Public health relevance
Project Narrative The successful funding and implementation of this administrative supplement to our parent application, “Regional Biocontainment Laboratory (RBL) Upgrade for Colorado State University (CSU)” is aimed to further support and maintain uninterrupted safe and efficient research in this facility. This facility direct supports its nationally mandated mission to “conduct research on biodefense and emerging infectious disease agents” and “be available and prepared to assist… efforts in the event of a bioterrorism or infectious disease emergency”, and demonstrated its call to this mission by pivoting its research landscape in response to the COVID global pandemic, and its integral role in infectious disease research, training and research support over the past 14 years. The investments proposed in this supplement further support this important mission.